Incidence, Outcomes, and Predictors of Sepsis in Hospitalized Patients with COVID-19

SARS-CoV-2 causes a wide spectrum of illness ranging from asymptomatic infection to multiorgan
failure and death. Patients infected with SARS-CoV-2 who develop organ dysfunction technically meet the
Third International Consensus Definitions of Sepsis and Septic Shock, which define sepsis as a dysregulated
host response to infection leading to life-threatening infection. Clinicians rarely frame severe COVID-19 as
sepsis, however, despite the fact that doing so could help rapidly convey the seriousness of the condition and
invoke existing hospital structures and management pathways to optimize care for this very ill subset of
patients. At the same time, severe COVID-19 likely has unique features that differentiate it from routine
bacterial sepsis as well as from other respiratory viruses.
The overall objective of this proposal is to characterize the incidence and outcomes for COVID-19-
associated sepsis, its risk factors, and how these compare to sepsis from influenza or bacterial infections. Our
proposed project will leverage objective definitions of sepsis and organ dysfunction based on CDC’s Adult
Sepsis Event criteria, a large database with detailed electronic health record data from five hospitals, and a
research group with extensive experience using big data to conduct innovative and impactful studies on
epidemiology, diagnosis, prevention, and treatment of sepsis, pneumonia, and other healthcare-associated
infections. In Aim 1 of our proposal, we will utilize state-of-the-art methods in sepsis surveillance to provide
rigorous estimates of sepsis incidence in COVID-19 and enable evidence-based comparisons between
outcomes and risk factors for sepsis due to COVID-19 versus influenza or bacterial infections. In Aim 2, we will
incorporate patient demographics, comorbidities, vital signs, and laboratory test results available at the time of
presentation in order to predict the development of sepsis in patients with COVID-19, allowing improved risk
stratification of patients at the time of presentation and more efficient hospital resource allocation.
The proposed work will have important public health impact by informing evidence-based comparisons
of COVID-19, influenza, and bacterial sepsis to guide public policy. Characterizing the distinctive features of
sepsis in COVID-19 could also help inform better risk stratification and management strategies and generate
hypotheses into the pathophysiology of severe COVID-19.
The award will also enable the candidate, Dr. Claire Shappell, to gain essential skills in data acquisition
and analysis, predictive modeling, use of statistical analysis software, and grantsmanship, enabling her to
achieve her long term objective of becoming an independently-funded physician-scientist with expertise in
mining the increasingly abundant clinical and physiologic data available via electronic health records (EHRs) in
order to characterize population trends and identify novel opportunities for care improvement in critical illness.

Public health relevance
PROJECT NARRATIVE Given the enormous and growing number of COVID-19 infections, an accurate and objective accounting of COVID-related sepsis is needed to modernize current estimates of the burden of sepsis in the United States. Rigorous comparisons between the incidence, outcomes, and risk factors for sepsis due to COVID-19 versus influenza and bacterial infections will inform evidence-based public health and resource allocation decisions including recognition, management, and prevention strategies, as well as inform hypotheses and provide insights into the pathophysiology of severe COVID-19. Finally, an accurate model to predict the development of sepsis in hospitalized patients with COVID-19 at the time of admission will enable improved, evidence-based risk-stratification and triage of patients in order to more efficiently utilize limited intensive care and nursing resources and improve clinician-patient communication regarding prognosis and severity of illness.